THE BOARD ON BEHAVIORAL, COGNITIVE, AND SENSORY SCIENCES (BBCSS)

The Board on Behavioral, Cognitive and Sensory Sciences (BBCSS) of the Academies monitors advances and developments in the behavioral, cognitive, and sensory sciences and serves as an intellectual resource for the National Academies of Sciences, Engineering, and Medicine and the research community. It does this in part through separately funded studies and workshops on subjects such as how people learn, the aging mind, visual impairment, and behavioral modeling and simulation. The Board also conducts core operations, which are funded by a consortium of agencies.